Defining the Regulatory Landscape of Lupus with CVD Comorbidity

PROJECT SUMMARY
Systemic lupus erythematosus (SLE) is an incurable autoimmune disease featuring large clinical heterogeneity
and multi-organ dysfunction, including cardiovascular diseases (CVD). Understanding this heterogeneity is vital
for accurate diagnosis, identifying therapeutic targets, providing personalized treatment, and improving patient
care. Lupus has a substantial genetic component, and studying immune cell-specific genetic architecture reveals
pathogenic mechanisms and therapeutic targets for SLE. Genome-wide association studies (GWAS) have
identified numerous SLE-predisposing loci, typically defined by blocks of correlated single nucleotide
polymorphisms (SNPs). GWAS loci are enriched in regulatory elements (REs) and can influence target gene
expression through regulatory SNPs (rSNPs). It is challenging but critical to identify the underlying causal
variants, target genes, and cell types involved in SLE pathogenesis. Monocyte-derived macrophages are pivotal
in atherosclerosis and SLE, as their dysfunction impairs phagocytosis and clearance of dead cells, contributing
to both diseases. Yet, the impact of SLE and CVD-associated variants on macrophage biology remains unclear.
Our central hypothesis is that some SLE rSNPs alter cis-regulatory elements (cREs) controlling target genes
involved in macrophage biology, fueling SLE and CVD. To test this hypothesis, we will perform systematic, high-
throughput, unbiased, large-scale studies in macrophages to determine the regulatory effects of 9,931 SNPs
within 182 SLE risk loci using induced pluripotent stem cells (iPSCs) from SLE patients and healthy donors. We
will differentiate iPSC-derived macrophage progenitors (monocytes) into unpolarized (M0), pro-inflammatory
(M1), and anti-inflammatory (regulatory, M2) phenotypes, recapitulating the natural molecular and functional
phenotypes of primary macrophages. Through our studies, we aim to identify dysfunctions arising from genetic
differences, and uncover regulatory elements and target genes in macrophages disrupted by SLE risk alleles.
Aim 1 will utilize the high-throughput technique, “self-transcribing active regulatory region-sequencing” (STARR-
seq) to screen thousands of SNP-containing regions for their regulatory potential in macrophages. Aim 2 will
employ next-generation (NG)-Capture-C to discover SNP-specific cis interactions with endogenous, cognate
target genes in macrophages. Aim 3 will apply CRISPR-Cas9 approaches to uncover the allele-specific
functional consequences of the top 10 selected rSNPs on their target gene(s) in iPSC-derived macrophages.
Also, to determine the potential association of SLE-associated risk alleles with CVD risk, we will analyze target
gene effects in primary monocytes/macrophages from SLE patients with or without atherosclerosis, as well as
healthy controls. Through this analysis, we aim to identify genetic factors contributing to both SLE and CVD,
gaining valuable insights into their interplay. This enhanced knowledge may inform targeted therapies or drug
repurposing strategies to address macrophage dysfunction in treating SLE and CVD.

Public health relevance
PROJECT NARRATIVE Several genome-wide association studies (GWAS), including our ongoing GWAS and follow-up meta-analyses, have identified >180 lupus (SLE) susceptibility loci, mostly defined by association with single nucleotide polymorphisms (SNPs) within gene regulatory regions. To comprehensively assess their functional impact en masse, we will employ high-throughput methods to simultaneously screen numerous SNP-containing regions, followed by genomic assays to validate and establish physical connections between these regulatory regions and their respective endogenous genes in distinct macrophage subtypes derived from induced pluripotent stem cells (iPSCs) from SLE patients and healthy individuals. This extensive knowledge will significantly enhance our understanding of SLE genetics, offer insights for in-depth mechanistic investigations into the development of atherosclerosis in certain SLE patients, and potentially identify therapeutic targets.